New England Regional Coordinating Center for the NINDS Stroke Trials Network

PROJECT SUMMARY/ABSTRACT
We propose to continue the StrokeNet New England Regional Coordinating Center (NERCC), an integrated
team of hospitals in the Greater Boston Area and suburbs, Western Massachusetts, New Hampshire and
Vermont that will serve as a top-enrolling site and vibrant contributor to the NINDS StrokeNet Clinical Trials
Network. Our group includes most of the major academic adult and pediatric stroke and rehabilitation hospitals
in Massachusetts, New Hampshire and Vermont. Our 30+ hospital New England TeleStroke referral network
will extend our potential recruitment and become particularly relevant with the upcoming STEP platform trials.
All core hospitals have a proven track record of successful management and performance of clinical trials. In
particular, all hospitals have an established research infrastructure that performs ongoing clinical research in
stroke neurology with strong collaborations across multiple disciplines. The leadership team composed of
Principal investigator Aneesh Singhal, MD, Deputy PI Natalia Rost MD, MPH, Site PIs, Deputy Site PIs, and
Co-Investigators bring a diverse and complementary set of skills in managing successful translational clinical
research programs, serving as members on trial Steering Committees, and positions of national leadership in
their fields. Our team includes seasoned clinical investigators in vascular neurology, emergency medicine,
neuroendovascular, neurosurgery, neurointensive care, neuroimaging, stroke rehabilitation, and preclinical
basic and translational stroke investigation in both adults and children. Strengths of the NERCC team include
1) close personal and professional ties between multiple investigators and site PIs; 2) a large patient
population with geographically diverse hospital settings anchored in a major metropolitan area; 3) talented
teams of site investigators with track records of scientific achievement, innovation, and subject recruitment in
multicenter trials; 4) robust existing NINDS-funded research and clinical trial management infrastructure at
most of the sites; 5) existing clinical research programs, e.g., MGH Neurological Clinical Research Institute,
NIH Clinical and Translational Science Award programs serving Boston University and all Harvard hospitals;
and 6) leadership roles in the SIREN-NETT, NeuroNEXT, DISCOVERY and MarkVCID trial networks. Overall,
the NERCC Team has demonstrated outstanding commitment and performance in the first two StrokeNet
cycles, and has the resources, vision, and enthusiasm to continue to develop new translational science and
successfully execute the NINDS StrokeNet Phase 1,2 and 3 trials.

Public health relevance
PROJECT NARRATIVE/RELEVANCE The New England Regional Coordinating Center of the NINDS StrokeNet includes 12 hospitals with nationally or internationally recognized patient care and clinical research programs: Baystate Health, Beth Israel Deaconess Medical Center, Boston Children's Hospital, Boston Medical Center, Brigham & Women's Hospital, Dartmouth Hitchcock Medical Center, Lahey Hospital, Massachusetts General Hospital, Spaulding Rehabilitation Hospital, Tufts Medical Center, University of Massachusetts Memorial Medical Center, and University of Vermont Medical Center. We have participated and contributed significantly to all StrokeNet trials.